Research Education Component

Massachusetts Alzheimer’s Disease Research Center: Research Education Component
The Research Education Component (REC) of the Massachusetts Alzheimer’s Disease Research Center
(MADRC) leads the Center’s efforts to develop junior investigators into future leaders in research on
Alzheimer’s disease and Alzheimer’s disease-related disorders (AD/ADRD). Research education has long
been a priority of the MADRC, and we are pleased to expand our efforts into a formal component. We build on
extensive experience as investigators and educators to foster the career development of junior investigators, to
develop inter-institutional programs to share expertise more broadly, and to help trainees learn the skills that
will contribute to our overall strategic goals of understanding heterogeneity and accelerating toward a
cure. We follow the same organizing principles as the MADRC as a whole. Under the heading of Marshal
resources for the core tasks of our component, a formal program to educate a cadre of trainees in cutting
edge cross-disciplinary research on AD/ADRD recognition, evaluation, care, mechanism, prevention, and
treatment, we plan to: Recruit and select a diverse cohort of trainees (Aim 1) and provide cross
disciplinary training and mentorship (Aim 2). Under Develop new strategies to achieve progress in the
field, we plan to provide intensive cutting edge clinical (Aim 3) and basic (Aim 4) research training
rotations to our own trainees and the broader scientific community. Under Build the future to move toward
new training approaches and the diverse workforce of the future, we plan to Develop cross-institutional
partnerships to facilitate research training (Aim 5) and to participate in pipeline programs to draw under-
represented groups into AD/ADRD research (Aim 6). We will recruit a group of five fellows who will be
designated "MADRC fellows" for 1-2 years, and provide intensive mentoring and a small stipend for training
expenses to attend meetings or exchanges with other ADRCs. We will recruit the fellows from a scientifically
and demographically diverse background, including both clinical and basic scientists. We will develop—for the
fellows and other local trainees-- a broad multidisciplinary training program and specialized rotations that will
also be available to those from other institutions and other ADRCs. The program is organized to take
advantage of the expertise and programs of the MADRC Cores and our large cadre of basic scientists to
broaden the training of our clinician scientists, and to meet the needs of basic science trainees.